ShEEP Request for EasyRatioPro Cell Imaging System

PROJECT SUMMARY Basic science VA investigators at our facility require the use of cell models for their research programs. This application is a request for the EasyRatioPro Imaging Platform. This is an integrated “turnkey” system will be able to monitor intracellular signaling mechanisms in the cell and tissue models investigated in VA funded projects. In summary, this system will enhance the capability of our research center to better understanding of underlying mechanisms responsible for the pathological conditions that lead to significant mortality and morbidity in the Veteran population.

Public health relevance
Public Health Relevance Statement Cells that model various pathological processes have played a vital part in medical breakthroughs in the past decade that have benefited the health care of Veterans. The imaging equipment requested in this application will be used to study intracellular signaling and protein interactions under pathological conditions that lead to significant mortality and morbidity in the Veteran population. Results of this proposed research will provide a better understanding of underlying mechanisms critical for designing new therapies for the prevention and treatment of these diseases.